Integrin activator-adjuvanted DNA vaccine against Trypanosoma cruzi infection

PROJECT SUMMARY/ABSTRACT
Trypanosoma cruzi (Tc) is the causative agent of Chagas disease (CD). With >7 million recorded cases, ~81
million at risk of Tc exposure in Latin America, and large-scale migration from endemic to other countries
including the USA where autochthonous transmission of Tc also occurs, CD remains a global health concern.
Currently no therapies exist to prophylactically treat adults traveling to endemic countries or those who may
already be infected with Tc. The economic burden for chagas cardiomyopathy and heart failure, estimated at
~$10 billion due to healthcare costs and lost productivity by premature deaths, provides a strong rationale for
investment in the development of immune therapies against CD. We have already developed a two-component
DNA vaccine (TcG2/TcG4) for CD and demonstrated preclinical efficacy of this prototype vaccine in controlling
Tc pathogenesis in a mouse model. Vaccine efficacy depends heavily on the induction of a robust TH1 response
for the clearance of intracellular pathogens like Tc. Integrin cell adhesion molecules α4β1 and αLβ2 and their
ligands, VCAM-1 and ICAM-1, respectively, play an essential role in the activation of adaptive immunity.
Prolonged integrin-mediated interactions between T cells and antigen presenting cells (APCs), particularly via
the αLβ2/ICAM-1 axis, are required for effective T cell priming and long-term T cell mediated memory.
Augmenting cell adhesion may facilitate T cell priming and subsequent immune responses. 7HP349 is a clinical-
stage, first-in-concept, oral, small-molecule, positive allosteric activator of α4β1 and αLβ2 integrins, which could
facilitate endogenous integrin ligand-receptor engagement, promote cell adhesion, and improve T helper function
and the effectiveness of CD vaccination. We have demonstrated that 7HP349 augments the effectiveness of the
prototype TcG2/TcG4 DNA vaccine in a mouse model of CD. Additionally, 7HP349 has a favorable preclinical
safety and pharmacokinetic profile, and was found to be safe and well tolerated in a Phase 1 clinical study in
healthy male subjects. In this SBIR grant application, we propose to develop a vaccination regimen for CD
consisting of a bicistronic DNA vaccine (BCV)-adjuvant combination with 7HP349 or another integrin activator,
7HP577, demonstrate preclinical efficacy and safety of the BCV-adjuvant combination, and manufacture clinical
grade cGMP BCV and adjuvant to support a Phase I/IIa clinical study to assess the safety and tolerability of the
vaccine-adjuvant combination, and thereafter to evaluate its immunogenicity in humans. The proposed studies
will allow the development of a novel vaccination regimen to prophylactically treat Tc infection and CD.

Public health relevance
PROJECT NARRATIVE Chagas disease (CD) is a global health concern, with no existing therapies to prophylactically treat adults traveling to endemic countries or those who may already be infected with Trypanosoma cruzi (Tc). This proposal aims to develop a vaccine-adjuvant combination comprising a DNA vector-based bicistronic vaccine (BCV) and a systemic small-molecule integrin activator adjuvant for the control of Tc infection and CD, and demonstrate preclinical proof-of-concept, efficacy and safety of this vaccine-adjuvant combination in preparation for a Phase I/IIa clinical trial.